Research Resources: Epigenomic and Transcriptomic Profile of Human Immune Cells

PROJECT SUMMARY
While an enormous number of genetic variants have been associated with risk for human disease, how these
variants affect gene expression in various cell types remains largely unknown. To address this gap as it relates
to immune cells, as well as to identify which immune cell types are most susceptible to the effects of disease-
risk variants, the DICE (Database of Immune Cell Expression, Expression quantitative trait loci (eQTLs) and
Epigenomics) project was established in 2014, funded by the current R24 resource grant (R24AI108564). Our
current datasets reveal the effects of disease risk-associated SNPs on common immune cell types (http://dice-
database.org). However, this dataset is far from complete; the effects of disease-risk variants on several very
important but rare and/or difficult to isolate cells, such as circulating innate immune cells and tissue-resident
immune cells, have yet to be studied. Having accomplished the aims of the first DICE grant, we now propose
to build on our findings through the following specific aims: In Aim 1, we will expand eQTL analysis to (A) Rare
circulating immune cell types such as dendritic cells, innate lymphoid cells (ILCs), invariant NKT cells, gdT cells
and CD4-CTL subsets, isolated from banked cryopreserved leukapheresis samples (>100) collected via the
DICE project, (B) circulating immune cells activated ex vivo, and (C) Tissue-resident memory (TRM) T cell types
such as CD8+ TRM, CD4+ TRM and tissue-resident NK cells isolated from lung tissue samples of 100 subjects to
map tissue-specific immune eQTLs tissue-resident immune cell types. In Aim 2, we will define long-range
enhancer-promoter 3D interactions in immune cell types to predict functionally important non-coding GWAS
SNPs. In Aim 3, we will expand our existing website (http://dice-database.org) to make current and newly
generated experimental data and analysis tools available to the community.

Public health relevance
PROJECT NARRATIVE/RELEVANCE For many human diseases, large-scale genomic studies have identified common genetic variants that occur more frequently in people with cardiovascular, autoimmune, inflammatory and infectious diseases, diabetes and asthma than in those without these diseases. Here we propose to understand how these variants cause susceptibility to disease, focusing on diseases related to the immune system, and use this information to find novel therapeutic targets for these diseases.